Cholinergic Modulation of Cochlear Plasticity

Project Summary
Adult outer hair cells (OHCs) modulate cochlear gain in the mammalian cochlea by amplifying mechanical
vibrations. Medial olivocochlear (MOC) efferent neurons originating in the brainstem modulate this gain by
hyperpolarizing OHCs via α9α10 cholinergic receptors (nAChRs) coupled to calcium-activated potassium
channels, forming a negative feedback loop. The MOC system improves neural representation of transient
signals in noise, protects the ear from overexposure to loud sounds, and mitigates age-related hearing loss
from accrued ambient sound exposures over time. Additionally, transient efferent inhibition of inner hair
cells (IHCs) during postnatal development, before hearing onset, contributes to functional maturation of the
peripheral and central auditory pathways. Intriguingly, age-related re-innervation of IHCs by efferent
synapses appears to recapitulate this developmental stage. Using novel genetically modified mouse
models, including mice with genetically enhanced or diminished MOC activity and fluorescently tagged
postsynaptic receptors, our prior work has delineated fundamental synaptic mechanisms of the MOC system,
characterized developmental consequences of genetic manipulation of MOC activity on the central auditory
system, identified its protective role against hearing dysfunction, and uncovered structural and functional
plasticity in MOC neurons associated with hearing loss and age. Most importantly, our mouse models of
enhanced MOC feedback show protection from damage produced by loud sounds and delayed progression of
age-related hearing loss, offering a potential target for clinical intervention. In the next phase of our work, we
propose to advance the mechanistic knowledge of α9α10 receptor-mediated cochlear inhibition and
expand its translational potential by pursuing three Specific Aims: 1) engineering olivocochlear inhibition to
protect against hearing dysfunction; 2) investigating efferent re-innervation after noise exposure and during
aging; 3) characterizing the effects of IHC-MOC manipulations during postnatal development. We will use
cutting-edge gene therapy via viral injection into the inner ear to boost MOC function in adult mice, track
changes in expression of HA-tagged α9α10 nAChRs with noise exposure and noise-accelerated cochlear
aging, and track development of auditory function in gain-of-function nAChR models exposed to different
acoustic environments. We will use detailed physiological, behavioral, and anatomical analyses to enhance
our understanding of cochlear efferent function and further elucidate preclinical manipulations of efferent
activity as potential therapeutic targets to prevent and/or delay hearing loss. Our combined expertise in
physiology, anatomy, and behavior brings a powerful integrative approach to studying the MOC system.

Public health relevance
Project Narrative The auditory olivocochlear efferent system modulates cochlear activity via specialized receptors that turn down the gain in the ear when activated, which is especially beneficial in the presence of noise. We will investigate the role of these receptors in auditory noise exposure, accelerated cochlear aging, and development using state-of-the-art genetic tools and detailed functional assays.